Mechanisms of Pathogenesis in Staphylococcal Enterotoxin B-Induced Acute Respiratory Distress Syndrome

PROJECT SUMMARY
Acute Respiratory Distress Syndrome (ARDS) is a severe condition characterized by non-compliant lung,
hypoxemia, protein-rich pulmonary edema, and cytokine storm. The COVID-19 pandemic highlighted ARDS
as a significant public health burden that annually affects approximately 200,000 patients in the US with a
35-45% mortality rate. ARDS develops via a myriad of etiologies, though the most common underlying
conditions in the US include pneumonia (44.9% of all cases) and nonpulmonary sepsis (46.8% of all cases).
The gram-positive bacterial pathogen Staphylococcus aureus is one of the most commonly isolated
pathogens in sepsis patients. S. aureus produces superantigens (SAgs), including Staphylococcal
Enterotoxin B (SEB). SEB exposure can induce ARDS by activating up to 30% of the naïve T cell pool
through the formation of non-specific cross-linkages between antigen-presenting cells (APCs) and T cells.
The receptors involved in this interaction are classically believed to include Vβ TCRs, CD28, CD80/CD86,
and MHC class II, though some studies suggest that MHC class II may be dispensable for inflammatory
response. Interestingly, recent studies have demonstrated that the SARS-CoV-2 Spike protein contains a
superantigen-like motif similar to SEB; additionally, the CDC has classified SEB as a Category B Biological
Agent due to its ease of dissemination and inhalation toxicity. Therefore, murine models of SEB-induced
ARDS can provide valuable insights into S. aureus and SARS-CoV-2 infection treatment, ARDS
pathogenesis and prevention, and biological weapon response. My preliminary data demonstrates that the
H2k C3H/HeJ mouse strain, but not the H2b C57BL/6J strain, are susceptible to SEB-induced ARDS, which
suggests that H2 haplotype may play a role in superantigen response. Therefore, the central hypothesis of
the proposed project is that C3H/HeJ mice are susceptible to SEB-induced ARDS due to alterations in MHC
Class II, Vβ TCRs, CD28, or CD80/CD86, which allow SEB to more effectively form cross-linkages between
APCs and T cells, thereby increasing SAg-mediated T cell activation and subsequent myeloid infiltration to
the alveoli. To test this hypothesis, I propose the following specific aims: 1) Establish the cellular and
molecular mechanisms of SEB-induced ARDS pathogenesis in C3H/HeJ and C57BL/6J mouse strains; 2)
Determine whether strain-specific differences in MHC Class II, Vβ TCRs, CD28, or CD80/CD86 drives
differential response to SEB in C3H/HeJ and C57BL/6J strains. The proposed experiments align with my
goals for fellowship training and will allow me the opportunity to gain expertise in high-throughput immune
cell profiling, transcriptome analysis, and in vivo approaches to elucidate immune response at the respiratory
site. Furthermore, the proposed professional development plan will propel my career goals by enhancing
my research independence.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic highlighted Acute Respiratory Distress Syndrome (ARDS) as a potent public health burden. It has been established that in comparison to C57BL/6J mouse strains, C3H/HeJ mouse strains are highly susceptible to ARDS induced by the superantigen Staphylococcal Enterotoxin B (SEB), which is excreted by the common pathogenic bacterium Staphylococcus aureus. This project aims to (i) characterize SEB-induced ARDS pathogenesis in C3H/HeJ mice and (ii) identify the immunological, genetic, and transcriptomic factors that contribute to both C3H/HeJ susceptibility and C57BL/6J resistance to SEB- induced ARDS.